Behavior and Physiology in Aging

PROJECT SUMMARY/ABSTRACT
The Duke Aging Center Postdoctoral Research Training Program (RTP) has a proud history of training highly
skilled research scientists with strong backgrounds or interests in aging and rich potential for leadership in
gerontological research. This proposal builds on the program’s legacy of success to continue and refine the
RTP to produce the next generation of leaders in the field of aging research. The Duke RTP focuses on aging
research from a biopsychosocial perspective, and is committed to cultivating deep understanding among the
post-doctoral fellows of the biological processes, psychological factors, and social forces that influence health
and well-being in late life. Consistent with this theme, the RTP faculty and their facilities enable outstanding
research training in the following areas related to aging: Biomedical Sciences; Social Sciences, Health services
Research and Biostatistics; and Behavioral and Neurosciences. Applicants to the Duke RTP identify a mentor
or mentors within the institution and work collaboratively with them to create an NIH-format research proposal
and submit it along with a curriculum vita, graduate transcripts, career and training plans, and letters of
recommendation. Fellows are integrated into their mentors’ research programs and mentored through
collaborative and independent research projects. Fellows attend a weekly interdisciplinary research seminar
that follows a structured curriculum on the biopsychosocial aspects of aging and the interdisciplinary nature of
aging research, as well as topics on professional development, research design and analysis, and research
ethics. Other didactic offerings are tailored to the individual fellows’ needs based on their individual
development plans (IDPs). Fellows typically complete two years in the RTP and go on to join university
faculties or research organizations. The Duke RTP supports 12 months of 100% protected time for research
and training related activities for up to 6 post-doctoral research fellows, and is requesting renewal of these
funds to continue this work. The Duke Center for the Study of Aging and Human Development is the primary
research training facility for fellows supported by this grant. Associated faculty are located throughout the
University and Medical Center.

Public health relevance
PROJECT NARRATIVE: The Duke Center for Aging Postdoctoral Research Training Program (RTP) trains scientists with rich potential for leadership in gerontology and/or geriatrics. It covers aging from an interdisciplinary biopsychosocial perspective and is highly relevant to public health concerns. This integrated translational approach to research in aging drives the generation of new investigators and new knowledge that can be applied to promote quality of life for older adults.